Histone Demethylases and Trophoblast Differentiationt

Abstract
Placental dysfunction leads to pregnancy-associated disorders, including intrauterine growth restriction
(IUGR) and preeclampsia, and also serves as a developmental cause for postnatal and adult diseases. Often,
the causal alterations in the placentation process, which lead to defective pregnancies, occur early in
gestation. Defective development and differentiation of trophoblast progenitors are leading causes for
pathological pregnancies. However, we have a poor understanding of molecular mechanisms that regulate
trophoblast progenitor self-renewal, differentiation and function in postimplantation embryos. Studies on
mutant mouse models and mouse trophoblast stem cells (mouse TSCs) implicated lysine-specific demethylase 1
(LSD1), the first identified histone demethylas, as a critical regulator to prevent premature differentiation of mouse
TSCs. However, the importance of LSD1 in the context of differentiated trophoblast cells of a matured placenta is
yet to be defined. Also, the importance of LSD1 in human trophoblast development has never been tested. Our
preliminary findings establish that LSD1 expression is conserved in trophoblast progenitors across mammalian
species, including humans. Thus, in this proposal we will investigate importance of LSD1 in the development of
specialized trophoblast cells, namely syncytiotrophoblasts (SynTBs) and invasive trophoblasts, at the maternal-
fetal interface. We will also define importance of LSD1 in human trophoblast differentiation and interrogate LSD1
function.
Two specific aims are proposed. Aim 1 will study Lsd1 conditional knockout mouse model to test the
hypothesis that cell-autonomous function of LSD1 in lineage-specific trophoblast progenitors ensures
establishment of differentiated SynTBs and invasive trophoblast cells at the maternal-fetal interface.
In Aim 2, using CTB-derived human trophoblast stem cells, we will test the hypothesis that LSD1
establishes a conserved gene expression program in mouse and human trophoblast progenitors and impairment
of LSD1-dependent transcriptional program will impair self-renewal and differentiation potential of human
trophoblast progenitors. In addition, we will also interrogate significance of LSD1-dependent mechanisms in the
context of pathological pregnancies.

Public health relevance
Relevance to Public Health: Defect in trophoblast lineage development results in early pregnancy loss or leads to pregnancies that are associated with pre-term birth, intrauterine growth restriction and preeclampsia, which cause serious adverse effects on maternal and infant health. These are major public health concerns. Therefore, a better understanding of trophoblast cell lineage development and function is critical to gain insights into important features of pregnancy loss and pregnancy associated disorders.